Impact of Allostatic Load and Neighborhood Contextual Factors on Breast Cancer in the Women's Health Initiative

PROJECT SUMMARY/ABSTRACT
Non-Hispanic Black (NHB) and Hispanic/Latinx women are disproportionately diagnosed with breast
tumor exhibiting more aggressive phenotypes; and NHB women are dying from breast cancer at rates
higher than every other racial/ethnic group in the United States (US). Due to structural racism (and its
downstream effects), NHB and Hispanic/Latinx women experience more chronic stressors compared
to non-Hispanic White (NHW) women. Emerging data, from our group and others, show that social and
biologic factors contribute to the development of breast cancers with more aggressive tumor features
that lead to the poorer outcomes. Evidence supports allostatic load – a measure of dysregulation across
major physiologic systems including metabolic, cardiovascular, and immune/inflammatory systems –
as a measure of cumulative physiologic stress and risk factor for adverse health outcomes. Data from
a nationally representative sample of US women showed that allostatic load is inversely associated
with socioeconomic status (SES) and positively associated with breast cancer among Black women,
but not White women. No prior study has prospectively explored the impact of allostatic load and
neighborhood contextual factors (simultaneously) on breast cancer in a large, diverse study sample.
Here we propose to examine the impact of pre-diagnostic allostatic load score (ALS) and objectively
measured neighborhood contextual factors on breast cancer incidence and phenotype in a large,
nested case-control study of NHB, NHW, and Hispanic/Latinx participants in the Women’s Health
Initiative (WHI). Our central hypothesis is that risk of breast cancer and aggressive tumors are
attributable to the impact of higher ALS and socioeconomically deprived and racially segregated
neighborhood context. Further, we hypothesize that allostatic load mediates the associations of
neighborhood context with breast cancer, which differ by race/ethnicity. Leveraging WHI’s prospective
design, rich epidemiologic and clinical data, and long-term follow-up, to test these hypotheses through
the following aims: 1) Investigate associations of allostatic load with breast cancer risk and tumor
phenotype; 2) Investigate associations of neighborhood contextual factors with breast cancer risk and
tumor phenotype; and 3) Evaluate whether independent associations of allostatic load and
neighborhood context with breast cancer differ by race/ethnicity. This study will have a high impact by
yielding novel, prospective data on the impact of unfavorable neighborhood contextual factors and
allostatic load (as an intermediate biological process/mechanism between neighborhood context and
health) on breast cancer. Findings from this study will contribute new knowledge about the biological
basis of long-term effects of structural racism and utility of ALS as a biomarker of cancer risk. These
data are essential to developing evidence-based prevention strategies to improve cancer health equity.

Public health relevance
PROJECT NARRATIVE This study is relevant to public health because it will prospectively examine the impact of disadvantageous neighborhood contextual factors (rooted in structural racism) and allostatic load (as an intermediate biological process/mechanism between neighborhood context and health) on breast cancer in a large, diverse study sample. The successful accomplishment of the proposed aims will contribute new knowledge about the impact of long-term exposures to disadvantageous neighborhoods and how chronic cumulative stress becomes biologically embedded in cells and tissues – thereby impacting breast cancer biology and etiology.